Central role of Caspase-8 in control of host tolerance and resistance mechanisms in pulmonary macrophage populations during severe respiratory infections

PROJECT SUMMARY
Pneumonia is an important global health problem1. Influenza A virus (IAV) leads to an estimated 500,000
deaths annually, and these numbers can be even higher during IAV pandemic years 2. A complication following
infection with IAV is bacterial pneumonia, and this can lead to a more severe disease 3–21. To survive a given
infection hosts must be able to not only clear the pathogen, but also tolerate to the effects of the pathogen or the
host response. The latter processes are referred to as disease tolerance. Normally, a balance between these
two processes is reached, and the infection resolves2223. My research lab has been at the forefront of exploring
the concept of host disease tolerance in deadly complex respiratory infections242322,25,26. We have shown that
during pulmonary IAV/bacterial coinfection this balance between resistance and tolerance is disrupted
causing increased lethality22,24.
Regulated cell death (RCD) plays important roles in both resistance and tolerance to infection. Cell death
can be broadly categorized as membrane permeable (e.g. necroptosis and pyroptosis) or membrane
impermeable (e.g. apoptosis). During infection several different types of cell death can be induced each inducing
a unique response. Macrophages are responsible for both resistance mechanisms such as coordination of the
immune response, and they contribute to tolerance in the form of the tissue repair responses after damage. This
proposal aims to bridge gaps in our current understanding of complex respiratory infections by investigating the
role of Caspase-8, a key regulator of RCD, in relevant in vitro and in vivo models of IAV/bacterial coinfection.
We will focus on understanding how Caspase-8 pathways in lung macrophages during IAV/bacterial coinfection
contributes to resistance and tolerance. Our preliminary data has demonstrated that Caspase-8 deficiency in
macrophages leads to increased host resistance at the expense of host tolerance in the early stages of
coinfection. This is most likely due to increased necroptosis and anti-microbial responses. We hypothesize that
during severe lung infections such as those that occur with bacterial infection following IAV infection
macrophage cell death controlled by Caspase-8 plays an important role in regulating the balance
between resistance and tolerance.
In this study we will determine the role that Caspase-8 in macrophages plays throughout the course of
infection. We will use relevant in vitro models using human primary macrophages, as well as in vivo models.
These studies will lay the foundation for future studies on understanding the impact of RCD in
macrophages during complex pulmonary infections, which may ultimately lead to improved treatment
options for patients with complex and severe lung infections.

Public health relevance
PROJECT NARRATIVE According to the WHO seasonal influenza epidemics causes 3-5 million illnesses and about half a million deaths each year, and a major cause of morbidity and mortality from influenza infection is caused by secondary infection with bacterial pathogens. This project focuses on the role of an innate immune cell subset, the macrophage, and in particular cell death responses in the overall ability to clear complex respiratory infections with minimal morbidity and mortality. This will allow us to better understand a fundamental concept of complex respiratory infections.